Optimizing suprachoroidal AAV delivery in nonhuman primates for retinal gene therapies

PROJECT SUMMARY
Adeno-associated viruses (AAVs) are widely employed for retinal gene therapies, but conventional routes of
administration have several challenges. Subretinal AAV delivery enables only focal transduction and risks
surgical complications from vitrectomy. Intravitreal AAV injections are easier to perform in the office, but do not
efficiently transduce photoreceptors and induce greater intraocular inflammation. We recently demonstrated the
successful use of transscleral microneedles to deliver AAV8 vectors into the suprachroidal space of nonhuman
primates (NHPs). Suprachoroidal AAV injections are more easily performed in the office and less invasive than
subretinal injections, and enable broad retinal transduction that cannot be achieved with intravitreal delivery.
Although suprachoroidal gene therapy has begun entering human clinical trials, our recent studies showed that
suprachoroidal AAV8 delivery has (1) restricted biodistribution to the peripheral retina, (2) limited cellular tropism
for mostly retinal pigment epithelium (RPE), and (3) short durability of transgene expression that may be
attributed to host immunity to viral transduction outside the blood-retinal barrier. We hypothesize that
suprachoroidal AAV delivery can overcome the limitations of conventional subretinal or intravitreal AAV
administration, if biodistribution, cellular tropism, durability, and safety can be properly optimized. In this study,
we will evaluate the use of microcatheterization, as well as the impact of increasing injection volume or viscosity,
to enhance posterior biodistribution of suprachoroidal AAV delivery to the macula. Next, we will screen a
barcoded library of naturally-occurring and engineered AAV capsids designed to penetrate the blood-brain
barrier in NHPs, with the goal of identifying and validating AAVs that can cross the blood-retinal barrier from the
suprachoroidal space to transduce photoreceptors. Finally, we will characterize host local and systemic immune
responses to capsids and transgenes after suprachoroidal AAV delivery by measuring aqueous and plasma
cytokines, neutralizing antibodies (NAbs), leukocyte responses, and cellular-level transcriptional profiling, with
and without systemic prophylaxis with corticosteroids or the sphingosine 1-phosphate receptor modulator
fingolimod. Together, our studies will address critical barriers to optimizing suprachoroidal injections as a novel
route of AAV administration for effective, safe, and durable gene therapy strategies to treat patients with retinal
diseases.

Public health relevance
PROJECT NARRATIVE Suprachoroidal injections of adeno-associated viruses (AAVs) enable broad transgene delivery for retinal gene therapy, but may be limited by lower biodistribution, cellular tropism, and durability than conventional subretinal or intravitreal delivery. This proposal seeks to enhance macular biodistribution, photoreceptor tropism, and the safety and durability of suprachoroidal gene therapy by (1) optimizing injection volume, viscosity, and device to achieve posterior spread, (2) testing AAVs engineered to overcome the blood-brain barrier, and (3) defining the cellular, molecular, and transcriptional profile of host immune responses to suprachoroidal vector delivery with and without steroid or immunomodulator prophylaxis. The goal of our proposal is to optimize suprachoroidal AAV injections as a safe and effective route for retinal gene therapy administration.